3D Printing of an immunocompetent, epidermal-dermal model

Project Summary/Abstract
Bacteria in biofilms, not individual or free swimming (ie planktonic) are responsible for 80% of all hospital
acquired infections, about 1.6 million infections and 80,000 deaths, at an annual cost of $16.8 to $27.2 billion
dollars in the US. Translational research for skin infections, like diabetic foot ulcers, burn wounds, and common
but increasingly recalcitrant impetigo in children, currently use agar plates, porcine skin extracts, live murine or
porcine models before clinical trials. However, porcine and murine models have distinct commensals and
immune responses. As part of the parent grant, we recently reported results showing the storage and loss
modulus (mechanical viscoelastic properties) of skin commensal biofilms, Cutibacterium acnes and
Staphylococcus epidermidis, are dependent on the type of substrate they are grown on: tryptic soy agar versus
reconstructed human epidermal tissue. Furthermore, commensal organisms can modulate the immune
response, including protecting against pathogenic species. This project seeks to develop 3D bioprinted tissue
constructs as a more representative and flexible model than the commercial skin.
The preliminary results showing distinct storage and loss modulus in response to being grown on agar versus
skin were shown using commercially available reconstructed human epidermal tissue. These are costly,
require a 6-week lead time, and are not useful for understanding mechanism as they come pre-assembled. We
seek to develop a protocol for rapid production of customizable vascularized human epidermal tissue. This
builds on success in the literature for producing reconstructed human epidermal tissue. It also builds on
success of a neighboring lab producing functional capillary layers on a chip. The challenges to be addressed
are (1) adding macrophages into the system; (2) reproducing these constructs using a 3D bioprinter; (3)
validating normal physiological response to temperature stress. Adding macrophages to the system will allow
in situ manipulation of the immune system and measurements of macrophage invasion into biofilms.
Reproducing these constructs using a 3D bioprinter will allow rapid assembly of the epidermis, dermis,
macrophage, and eventual vascular layer. The vascular layer will allow heat flux away from the system which
is necessary for studying the impacts of climate change on the system. Even meeting these challenges will not
bring the system to the point where it will replace murine and porcine models. The remaining challenges will
include functionalizing the skin with human commensal organisms; architecting pores; and inducing the
perspiration response.

Public health relevance
Project Narrative Research for treating skin infections - like diabetic foot ulcers, burn wounds, and common but increasingly hard to treat impetigo in children - currently use agar plates, pig skin, and live mice or pig models before clinical trials. Cosmetics research use costly but biologically simple reconstructed skin, about 30 layers of human skin cells, to measure allergic response. This project seeks to develop protocols for 3D bioprinting skin tissue with immune cells and blood vessels for infectious disease research.